Dopaminergic Control of Glial Cells in Prefrontal Cortex Functions

Project Summary
Recent research in the study of brain functions is highlighting the important role of glial cells in
several human neurological and psychiatric disorders. The dopaminergic control of brain
functions is classically assigned to the effect of dopamine on neurons. However, D2R
expression has also been reported in astrocytes, questioning what their contribution in the
dopamine-dependent control of brain functions is.
Based on preliminary evidence showing an increase of astrocytes and microglia in the PFC of
mice with an altered control over dopamine synthesis and release, we hypothesize that D2R
signaling in astrocytes influences the activity of neighboring cells and induces microglia
proliferation. This mechanism could play a role in the control of PFC dependent behavior, gene
expression in astrocytes and microglia, as well as on the metabolites that they produce.
Thus, we propose to perform experiments to determine the impact of D2R signaling in astrocyte
on PFC functions. We will use viral vectors to knockdown D2R specifically in astrocytes in mice
with either a normal control of dopamine synthesis and release or in mutants where these
functions have been altered. This project is timely due to the increased involvement of glia in
brain disorders and promises to elucidate mechanisms previously unexplored.

Public health relevance
Project Narrative Astrocytes are cells highly abundant in the brain where they play important roles in the maintenance of homeostasis. Recent evidence show that astrocytes are involved in neurological and neuropsychiatric disorders. Astrocytes have been reported to express the dopamine D2 receptors, a major player of the dopaminergic control of brain functions. This proposal aims at determining the role of D2R in astrocytes and possible implication in the control of brain disorders.